EHD4 and its role on HIV-1 infection

PROJECT SUMMARY/ABSTRACT
Antiretroviral therapies for those infected with human immunodeficiency virus-1 (HIV-1) have been effective in
controlling infection however they must be taken for life and have many short-term and long-term side effects.
Understanding host-pathogen interactions between cellular and HIV-1 proteins may reveal cellular factors that
are involved in viral replication that can serve as targets for the development of novel antiretroviral therapeutics.
During virion production, HIV-1 envelope glycoproteins are internalized into early endosomes and recycled to
sites of viral assembly at the plasma membrane. Eps15 Homology Domain Protein 4 (EHD4), a cellular protein,
known to be involved in endocytic recycling of membrane proteins/receptors, directs internalized proteins at early
endosomes to late endosomes for subsequent degradation in lysosomes. However, recent data suggest a novel
role for EHD4 as an HIV-1 restriction factor. Preliminary data demonstrate EHD4 decreases HIV-1 particle
infectivity and reduces envelope glycoprotein levels (gp41 and gp120) in nascent virions. Furthermore, EHD4
does not affect the surface levels of CD4, CXCR4 and CCR5, thus its effect on HIV-1 infection is not indirect.
Finally, we show that gp41 forms a complex with EHD4. While EHD4 is an interferon stimulated gene, nothing
is known about its antiviral functions. The objective of this proposal is to determine the mechanism by which
EHD4 decreases HIV-1 particle infectivity. The experiments proposed in this research plan will further
characterize the antiviral role of EHD4 during HIV-1 infection by 1) determining the mechanism by which EHD4
blocks the incorporation of envelope glycoproteins, gp41 and gp120, in nascent virions, 2) investigating the role
of EHD4 found in virions, and 3) elucidating the role of the gp41 cytoplasmic tail on EHD4-mediated restriction
of HIV-1. Additionally, experiments performed to characterize the role of EHD4 will include both primary CD4+ T
cells and monocyte derived macrophages (MDMs) infected with HIV-1 to reflect infection under physiological
conditions. The proposed research will provide essential insight into the role of EHD4 during HIV-1 infection and
may identify novel drug targets that lead to improved antiretroviral therapies. Finally, our findings with HIV-1 have
the potential of being applicable to other enveloped viruses.

Public health relevance
PROJECT NARRATIVE The HIV/AIDS pandemic is a global public health crisis and current therapies, while effective, have numerous long-term side effects which highlights the need for improved therapies. Our research has focused on identifying factors that significantly reduces HIV-1 replication by targeting the viral envelope. Our proposed research will characterize how a host gene suppresses HIV-1 replication which may lead to new targets for novel therapies for HIV/AIDS.